Autophagy, injury, and plasticity in the intestinal regenerative process

PROJECT SUMMARY
The intestinal lining is supported via maintenance of a layer of intestinal epithelial cells, and in particular, intestinal
stem cells (ISCs). ISCs are very sensitive to cell death in response to various injuries, including radiation,
chemotherapy, or inflammation. In the face of ISC depletion, the epithelial layer can still efficiently regenerate
due to the contribution of other cells that can re-acquire ISC activity when needed, termed “facultative” intestinal
stem cells (f-ISCs). F-ISCs must possess two fundamental attributes: 1) injury resistance, and 2) the ability to
re-acquire ISC activity. These attributes together ensure replenishment of the epithelial lining in response to
tissue damage. Despite the critical importance of f-ISC activity in the regenerative response, little is known about
its molecular basis. Emerging evidence implicates autophagy as a key player in this process.
Genetic inactivation of autophagy leads to reduced regeneration after epithelial injury, and
polymorphisms in autophagy genes are associated with susceptibility to Crohn's disease. Conversely, calorie
restriction or fasting, which can induce autophagy, is associated with enhanced intestinal regeneration. Our
recent publication showed that intestinal cells with high autophagic vesicle content are relatively resistant to DNA
damage compared to ISCs in vivo. We also find that high autophagic vesicle content in intestinal epithelial cells,
particularly differentiated secretory cells, is associated with enhanced organoid formation- an in vitro proxy for
ISCs. These data suggest that high autophagic vesicle content can prospectively identify secretory cells that are
f-ISCs in vitro, however, whether certain lineages are better “poised” to be f-ISCs and the mechanistic
contribution of autophagy to both injury resistance and regeneration are critical knowledge gaps. The current
proposal will use in vivo models and organoids from both mice and humans to define how autophagy contributes
to cells that survive injury and re-enter the cell cycle to drive regeneration. Aim 1 will define whether autophagy,
and specifically mitophagy, underlies DNA damage resistance of f-ISCs. Key findings will be confirmed in
enteroids and colonoids from de-identified healthy human subjects. Aim 2 will define the extent to which
autophagy-mediated f-ISCs utilize a TGF-mediated fetal gene expression program to contribute to tissue
regeneration. Key facets of Aim 2 will be evaluated directly in human organoid lines. Our study will provide a
significant conceptual advance in understanding how non-ISCs with high autophagy can repurpose
themselves as f-ISCs to contribute to epithelial barrier restoration. In addition, these studies are highly
impactful because they will directly translate key findings in primary human cells. Resulting data will
form a basis for enhancing f-ISCs for clinical benefit in patients with GI diseases.

Public health relevance
PROJECT NARRATIVE This proposal aims to understand how cells that line the lower gastrointestinal tract can repurpose themselves when needed to regenerate the tissue during damage or disease. Successful completion of these studies will support the development of novel strategies to enhance injury resistance and promote healing of the intestinal lining in patients undergoing cancer treatment with harmful gastrointestinal side effects, or in patients with gastrointestinal diseases such as inflammatory bowel disease.